RECOMBINANT METHIONYL INTERFERON CONSENSUS IN CHRONIC HEPATITIS C

To determine the efficacy of two dose levels of r-metIFN-Con1 in chronic hepatitic C virus infected patients. Efficacy will be measured by changes in serum values before and after treatment. And, to assess the tolerability, efficacy, immunogenicity and durability of response at the end of 24 week post-treatment observation period.